RIFAPENTINE CLINICAL TRIAL--RISK FACTORS FOR RELAPSE AMONG HIV+ PTS

The primary objective of this protocol is to study INH and rifamycin pharmacokinetics in HIV serpositive tuberculosis patients in the Rifapentine clinical trial.